Investigating the Role of Cancer-Associated Fibroblasts in Immunodetection of Mycosis Fungoides

Cancer-associated fibroblasts (CAFs) are abundant components of the tumor microenvironment in the skin of
early-stage mycosis fungoides (MF) patients. Evidence suggests CAFs promote the progression of early-stage
MF to late-stage MF by suppressing the tumor surveillance function of the immune system. Currently, little is
known about the CAFs responsible for immune evasion and disease progression in MF or how this differs by
patient demographics or stage of disease. As CAFs are heterogeneous cells, investigating CAFs requires novel
molecular techniques that account for the diversity of cell populations and can determine the location of critical
subtypes. The Research Training Plan will use the novel molecular techniques of single-cell RNA sequencing
(AIM 1) and spatial RNA transcriptomics (AIM 2) to uncover the subtypes and location of CAFs responsible for
immune evasion and MF progression from a diverse patient population. In Aim 1, Dr. Johnson will work with
mentor Dr. Winston Timp and advisor Dr. Ron Sweren to obtain patient samples, dissociate whole skin tissue,
and perform single-cell RNA sequencing on patients from diverse stages and demographics in the K99 phase.
Dr. Johnson will train with advisors, Drs. Elana Fertig and Stephanie Hicks to develop computational analysis
and apply statistical models to identify subtypes of CAFs based on gene expression. Advisor Dr. Jaroslaw
Jedrych will provide guidance with immunohistochemistry verification of gene biomarkers. The R00 phase will
include the analysis to identify biomarkers relevant to MF disease diagnosis and prognosis in this diverse patient
population. In Aim 2, Dr. Johnson will work with mentor Dr. Winston Timp and collaborator Dr. Elana Fertig to
execute spatial RNA sequencing techniques and acquire computational analysis to integrate single-cell RNA
sequencing data with spatial RNA sequencing data to locate the subtypes of CAFs identified in AIM 1 in the K99
period. The R00 period will further explore all cells within the tumor microenvironment to uncover candidate
cytokines and receptors responsible for crosstalk pathways between the MF tumor cells and the CAF subtypes
of interest. Dr. Johnson has had some prior training in single-cell RNA sequencing and analysis and expertise in
skin biology. The Career Development Plan is tailored to enable Dr. Johnson to develop computational analytical
skills and refine her statistical analysis of single-cell and spatial data while gaining valuable background skills
through coursework. Mentor Dr. Winston Timp is a leading expert in sequencing and genomics. Advisors Dr.
Stephanie Hicks, an expert in single-cell statistical analysis, and Dr. Elana Fertig, an innovator in computational
analysis of integrative transcriptomics, offer complementary expertise. The JHU Department of Dermatology and
Biomedical Engineering environment is an outstanding collaborative setting with excellent core facilities and
biorepositories infrastructure. In summary, the strong mentoring environment and training plan are anticipated to
prepare Dr. Johnson to launch her independent career. The proposed studies will offer mechanistic insights into
the pathogenesis of MF progression and immune evasion in a diverse patient population.

Public health relevance
Project Narrative Some patients with mycosis fungoides (MF), a skin cancer, will progress to late-stage disease with involvement beyond the skin and a higher mortality risk. This study will investigate the subtypes and the location of cancer- associated fibroblasts (CAFs) responsible for immune evasion of MF tumor cells in the skin of diverse patient populations. Results obtained here will provide insights into the role of the tumor microenvironment in the progression of MF and identify potential targets for more direct personalized therapies to improve overall survival.